Efficacy of combined inhibition of BRAF, MEK, and FAK in melanoma patient derived xenografts

Summary ?This application is being submitted in response to the Notice of Special Interest (NOSI) identified as NOT-CA-21-009.? Significant advances in melanoma research have resulted in new therapies that have remarkably improved the management and overall survival of melanoma. However, many patients still succumb to the disease and more than half of all melanoma deaths are due to brain metastases. As a means to overcome this challenge, we developed a novel mouse model that allows postnatal delivery of genes of interest to melanocytes. Using genomic and proteomic data from human melanoma samples, we tested several gene combinations for their ability to induce metastatic melanoma in vivo. Hyperactivation of the PI3K/AKT pathway in the context of mutant BRAF and CDKN2A loss resulted in the development of spontaneous melanoma with full penetrance and a mean survival of only 6 weeks. The majority of these mice also developed multiple metastases to the lungs and brain. This model mimics the human disease genetically, histologically, and by sites of metastasis. Importantly, this model system provides a powerful platform to further study the mechanisms of melanoma metastasis. Elucidation of this network will allow the identification of key pathway nodes that represent potential therapeutic targets to disrupt this process. We used next generation sequencing and proteomics analysis of non-metastatic and metastatic tumor samples to identify downstream targets of AKT1 implicated in melanoma brain metastasis. Our data showed that tumors expressing activated AKT1 displayed elevated levels of focal adhesion (FA) factors and phosphorylated focal adhesion kinase (P-FAK). In addition, mutant AKT1 expression increased invasion and this was reduced by pharmacological inhibition of either AKT or FAK. Moreover, loss of PTEN, which also results in increased FAK activity, cooperated with activated AKT1 to further enhance brain metastasis in vivo. Despite these promising preliminary findings, a critical gap still remains in determining whether the AKT1-FAK-PTEN axis can be exploited as a therapeutic target in this disease. Our long-term goal is to use this knowledge to develop novel melanoma therapies and improve patient outcomes. Pursuant to this goal, we have formed a collaboration with Drs. Menhard Herlyn and Michael Davies, Principal Investigators of the U54-funded melanoma PDX program. This collaboration will bring together the melanoma PDX expertise of Drs. Herlyn and Davies with the AKT-FAK-PTEN signaling expertise of Dr. Holmen. Together, we will test the hypothesis that combined inhibition of BRAF, MEK, and FAK will inhibit the growth of primary melanoma as well as established brain metastases. Successful completion of the aims in this proposal will significantly impact the field by laying the groundwork for translation into clinical trials, leading to new and better treatments for patients with brain metastases and those who are at high risk of developing brain metastases.

Public health relevance
Project Narrative Recently approved therapies have shown unprecedented promise in advanced stages of melanoma but clinical management of brain metastases remains challenging. This project strives to determine whether inhibition of focal adhesion kinase, a mediator of melanoma brain metastasis, in combination with standard of care targeted therapy is a rational therapeutic strategy in this disease.